Modulation of protracted opioid withdrawal by dorsal raphe dynorphin neurons

Project summary
Opioid use disorder (OUD) is a chronic relapsing disorder that has cost the U.S. more than $1 trillion in 2017
alone. While initially driven by brain reward circuits, opioid consumption increasingly engages stress-related
neural circuits that drive maladaptive emotional states. During the abstinent weeks, months, and years following
opioid use, the risk of relapse is increased by emotional symptoms, such as social avoidance, depression, and
opioid cravings. Similarly, tendencies to self-isolate during periods of protracted opioid withdrawal increase the
risk of lethal overdose. The rapid escalation of opioid overdoses in the U.S. reflects the need for more data on
neural mechanisms underlying protracted opioid withdrawal. The neuropeptide dynorphin and kappa opioid
receptors (KOR) contribute to stress, aversion, and behavioral consequences of withdrawal. While evidence
suggests that KOR effects may be due to modulation of dopamine and serotonin release in the nucleus
accumbens (NAc), the brain regions and neural mechanisms mediating KOR control of opioid withdrawal remain
a critical gap in knowledge. In this K99/R00 pathway to independence award, I aim to identify mechanisms by
which KORs mediate changes in behavior during withdrawal. Using a mouse model of chronic, non-contingent
morphine exposure, I have collected preliminary data indicating that 1) KOR activity in the NAc controls social
avoidance and anhedonia produced during protracted withdrawal and 2) a population of dynorphin-producing
neurons in the dorsal raphe nucleus, but not dynorphin neurons in the NAc itself, mediate the same effects.
During the mentored phase, in Aim 1, I will learn to perform in vivo optogenetic procedures and fiber photometry
recordings to characterize the role of dorsal raphe dynorphin neuron projections to the NAc in withdrawal
behaviors. In Aim 2, I will expand on the model of non-contingent injections and establish a new model of
remifentanil self-administration and examine relapse behavior during protracted withdrawal. I will also test
changes in social and depression-like behaviors after self-administration. In the independent phase, in Aim 3, I
will use my training from the K99 phase to combine optogenetics and fiber photometry recordings of dorsal raphe
dynorphin inputs to the NAc with remifentanil self-administration and relapse testing. In Aim 4, I will expand on
additional preliminary data collected with non-contingent injections showing that KOR expression in serotonin
and dopamine neurons is critical for social avoidance and depression-like behaviors, respectively. I will use fiber
photometry and fluorescent sensors of dopamine and serotonin to record release in the NAc during protracted
withdrawal testing. In addition, I will examine dopamine and serotonin dynamics in the self-administration model
developed in Aim 2 by testing mice with the same cell-type specific KOR knockouts and performing photometry
recordings of release in the NAc. Overall, this proposal will investigate key mechanisms underlying protracted
opioid withdrawal with a combination of advanced techniques, while simultaneously providing me with the tools
necessary for establishing an independent research program aimed at dissecting the pathogenesis of OUD.

Public health relevance
Project narrative Significant increases in opioid use disorder (OUD) cases has led to the opioid crisis and incurred a massive economic and societal burden. The proposed study will investigate the circuits, cell-types and neurochemicals mediating opioid withdrawal and relapse. Results obtained here will provide key insights into the mechanisms underlying OUD and promote the development of therapeutic approaches to improve behavioral deficits and prevent relapse in humans afflicted with OUD.